Disease consequences and regulation of autophagy-independent ATG3 activity

Project Summary/Abstract
Macroautophagy is a degradative cellular process that is upregulated in response to stress. Dysregulation of
autophagy is broadly associated with several diseases including cancer, aging, and neurodegeneration.
However, since this process is essential for mammalian development, diseases affecting core autophagy
genes are very rare. For example, ATG3 is a core autophagy gene that is crucial for the formation of the
autophagosome and there are no known disease-causing mutations within this gene. Interestingly, there is a
patient with an undiagnosed severe neurodevelopmental disease found to have a point mutation in a single
allele of the ATG3 gene. Intriguingly, ATG3 has been implicated in other conjugations thought to be
independent of autophagy. These other conjugations regulate mitochondria and endolysosomal trafficking,
both of which have significant roles in neurologic disease. My thesis work has largely focused on the patient
mutation and its effect on autophagy, but my preliminary data indicates that all ATG3 activities appear to be
disrupted in patient cells. Therefore, I propose to develop tools to further understand the cell biological
consequences of these non-canonical ATG3 activities and use these tools to understand the effect of
the patient mutation beyond autophagy. This project is designed to provide training for a successful future
career in independent research. The findings from this project will improve the understanding of complex
cellular processes and how they can result in disease.
This proposal focuses on two aims: Aim One – Determine the impact of a patient mutation on lipidation-
independent activities of ATG3; Aim Two – Determine if lipidation-independent ATG3 activity is dependent on
membrane binding. Aim One will use microscopy techniques I developed in patient cells and a knockout-
rescue strategy in gene-edited cells to directly evaluate the impact of the mutation on the formation and
downstream consequences of these autophagy-independent complexes. Aim Two will capitalize on the
techniques established in Aim One and biochemical experiments routinely performed in our lab to investigate
potential mechanisms by which these autophagy-independent ATG3 complexes are regulated and function.
The work in this proposal detailing the effect of this ATG3 mutation has the potential to describe the first severe
disease-producing allele of ATG3. Additionally, this work aims to distinguish and characterize previously
inseparable ATG3 functions, leading to a new understanding of both foundational biological processes and
their downstream clinical relevance.

Public health relevance
Project Narrative Autophagy dysfunction is broadly implicated in promoting diseases ranging from neurodegeneration to aging to cancer. The fundamental autophagy protein ATG3 plays an understudied role in regulating mitochondria and endosomes, and dysregulation of these organelles are also linked to neurologic diseases. Here, I explore the cell biological consequences of a mutation to ATG3 that drives neurological disease, as well as the greater cellular consequences of these non-canonical ATG3 activities.